Understanding glaucoma risk and assessment of precision therapies: A study of mitochondria and oxidative stress in human trabecular meshwork

Modified Project Summary/Abstract Section
Understanding the pathogenesis of glaucoma, a leading cause of blindness worldwide, is an important goal of vision research. As indicated in numerous population-based studies, individuals of various genetic profiles develop glaucoma at an earlier age with increased severity and risk of blindness. Many studies have identified oxidative damage to the trabecular meshwork (TM) cells, leading to decreased outflow facility and increased intraocular pressure. Although the evidence linking oxidative damage to glaucoma is strong, the causes of oxidative damage in glaucoma are not known. In the proposed studies, we will test the hypothesis that oxidative damage to the TM is associated with basic genetic and physiologic differences in oxygen metabolism leading to disparities in glaucoma. Our hypothesis is based on intraocular measurements of oxygen partial pressure (pO2) made in the human eye during surgery. We identified strong correlations between pO2 and important risk factors for glaucoma, including central corneal thickness. In addition, measurements of a cell marker for DNA oxidative damage were elevated in the aqueous humor of patients with severe glaucoma. Cultured TM cells from healthy donors compared to glaucomatous cells had altered energy (ATP) and reactive oxygen species production, implicating the energy processing organelles, the mitochondria. Our specific aims will test these hypotheses: (Aim 1) will evaluate differences in TM gene expression between donor controls and patients at various glaucoma stages in order to identify the genetic basis of disparities in tissue function (controlling eye pressure) and susceptibility to damage. Genes of interest will be further studied (RT-qPCR, in situ hybridization) and delineate protein expression (Western blot) in the tissue and potential biological pathways involved, focusing on mitochondrial function, oxidative stress and antioxidant protection. (Aim 2A) will study mitochondrial functions in primary human TM cell cultures from specimens of healthy donor controls and glaucoma patients at various severity stages. We will determine the effects of exposure to varying levels of pO2 on detailed analyses of mitochondrial quantities and function, reactive oxygen species levels and antioxidant protection. (Aim 2B) will also assess the cellular effects of potential antioxidative therapies. The proposed research is innovative because understanding these physiological mechanisms potentially contributing to disease based on genetic ancestry, confirmed by blood and tissue ancestral genotyping and mitochondrial DNA haplogroup stratification, will provide important information about the pathophysiology of open angle glaucoma by identifying factors responsible for the TM dysfunction and loss of aqueous outflow facility. The knowledge gained in these studies may lead to new therapies and strategies to prevent this blinding disease.

Public health relevance
Modified Public Health Relevance Section Glaucoma, a leading cause of blindness worldwide and frequent cause of visual impairment in the US, is an important public health issue, affecting particular individuals at an earlier age and more commonly resulting in blindness. By exploring the tissue-specific genetic and physiologic basis of these differences, our research will provide support for our hypothesis proposing differences in oxygen/mitochondrial metabolism and oxidative stress (from “toxic” free radicals) within the tissues (trabecular meshwork) of the drain of the eye that controls eye pressure, the most significant modifiable risk factor for glaucoma. Improving our understanding of how certain individuals are more susceptible to damage will also expand potential novel pathways of therapy and prevention for all individuals afflicted by or at risk for this blinding disease.